Redox regulation of protein kinase function: biochemical mechanisms and cellular consequences

SUMMARY. My research program focuses on understanding the organization and regulation of
phosphorylation-dependent signaling networks in health and disease. In particular, we are interested in
deciphering the biochemical and cellular mechanisms of crosstalk between phosphorylation-dependent
signaling and other signaling pathways at the level of posttranslational modification of protein kinases. One
attractive modification is reversible oxidation, mediated by reactive oxygen species (ROS). ROS are emerging
as critical second messengers in signaling pathways related to many pervasive diseases, including diabetes,
cancer, and cardiovascular disease. A growing body of evidence suggests that protein kinases are directly
regulated by redox modifications. For instance, the reversible oxidation of Cys residues in redox-sensitive
kinases has been shown to influence their activity (both positively and negatively), subcellular localization, and
protein-protein interactions. In many cases, the modified Cys is conserved among other members in the same
kinase family. This raises the intriguing possibility that reversible oxidation may be a general means of regulating
kinase function inside cells. To explore this possibility further, we are examining the impact of H2O2-depedent
oxidation on the global substrate selection of several mitogen-activated protein kinase (MAPK) and AGC family
members using functional protein microarrays and complementary biochemical, biophysical, mutational,
computational, and cell-based strategies. Our data suggest that H2O2-dependent oxidation shifts the substrate
preference of many kinases, leading to distinct substrate profiles in the oxidized and reduced states. For
instance, with support of an NIGMS SC1 award (5SC1GM130545), we are currently studying the biochemical
mechanisms underlying the H2O2-induced shifts in the substrate selection of the canonical AGC and MAPK
family members, PKA-Cα and ERK2. These studies suggest that reversible oxidation of PKA-Cα and ERK2
increases their affinity for some substrates while decreasing or having little effect on others. Interestingly,
different types of redox modification (e.g., diamide-mediated oxidation, H2O2-dependent oxidation, or
glutathionylation) led to different activity profiles toward the same model substrates. With support from the
proposed MIRA, we propose to build on these studies by asking questions about 1) the effects of redox
modification of kinase substrate selection in various cellular contexts and their impact on signaling outcomes
related to disease; 2) the impact of redox modification on the spatiotemporal regulation of kinase activity profiles
in cells; and 3) how the global substrate profiles of other protein kinases, including understudied kinases in the
“dark kinome”, are affected by H2O2-dependent oxidation and/or different types of redox modifications. Together,
these studies will offer unique insights into mechanisms of crosstalk between redox- and phosphorylation-
dependent signaling pathways in physiological & pathological processes. Importantly, a MIRA will also facilitate
mentoring of trainees from underrepresented minority groups, promoting diversity of the biomedical workforce.

Public health relevance
PROJECT NARRATIVE During the five-year project period, we will investigate key questions related to 1) the biochemical mechanisms underlying oxidation-induced changes in protein kinase substrate selection and 2) the functional consequences of redox modification on kinase-dependent signaling processes related to health and disease. To this end, we will build upon our recent studies, which focused on PKA-Cα and ERK2 as representative members of the AGC and MAPK kinase families, to explore the impact of redox modification on the global substrate selection of other kinase family members (including several understudied kinases in the “dark kinome”) using functional protein microarrays composed of >21,000 unique human proteins. Together, these studies will help identify points of signal integration between redox- and phosphorylation-dependent pathways while complementing existing models of pathological oxidative stress and providing new opportunities for targeted antioxidant therapeutics for many diseases (e.g., cancer, diabetes, cardiovascular disease, and several neurodegenerative disorders).